Identification of cell-type specific visual circuits in the ventral lateral geniculate nucleus

PROJECT SUMMARY
Information about the visual world is captured by the retina and transmitted by retinal ganglion cells (RGCs) to
a diverse array of retino-recipient regions of the mammalian brain, including those in thalamic, hypothalamic,
and midbrain regions. There is an organizational logic to these long-range retinal projections where RGCs, of
which there are more than three dozen morphologically and functionally distinct subtypes, project to distinct
and sometimes mutually exclusive retinorecipient regions. Many of these retinorecipient nuclei are critical to
the execution of specific visual behaviors. To understand how visual information is processed and transmitted
from the retina to these brain regions requires a detailed characterization of the full cohort of cells in both
regions and an investigation into the types of circuits they are assembled into. This requires us to catalogue a
cellular “parts list” in both the retina and brain. For some parts of the subcortical visual system, such a
catalogue exists. However, for some retino-recipient nuclei the cellular parts list is either poorly characterized
or missing. One such region that remains poorly characterized is the ventral lateral geniculate nucleus (vLGN),
the third largest retino-recipient region in rodents. Therefore, our goal is to apply state-of-the-art single cell
resolution transcriptomic sequencing with trans-synaptic viral tracing to identify, in an unbiased fashion, all
types of retino-recipient cells in the vLGN. Two such cell types have been identified in preliminary studies
(Pvalb+ and Penk+ cells) and surprisingly, these cell types occupy distinct, adjacent sublamina of vLGN. These
anatomical divisions suggest that subtype-specific laminar distribution of retino-recipient cells in this region
may be important for receiving, processing, and transmitting light-derived signals in parallel channels through
the brain. We will test this hypothesis by identifying the specific inputs and outputs of these two subtypes of
vLGN neurons.

Public health relevance
PROJECT NARRATIVE Visual impairment imparts major social and economic burdens on the US population. Currently, there are no effective therapies to regenerate visual circuits and restore vision in affected persons, and our ability to study these circuits and regenerate visual circuits, is hindered by a lack of fundamental understanding of the specific cell types in regions of the subcortical visual system. In response to this gap in knowledge, we aim to identify and characterize the “parts list” of all cells in the ventral visual thalamus.